Digital Transformation to Reduce Social Isolation and Improve the Engagement, Care, and Support of Individuals Living with Alzheimer's Disease and Related Dementias: Diversity Supplement

Social isolation and loneliness accelerate cognitive and functional decline, increase premature mortality, and
significantly reduce quality of life in older Americans. Social isolation and loneliness are associated with $6.7
billion in additional Medicare spending annually, and are key drivers of inefficient, ineffective, and costly care.
Individuals living with Alzheimer’s disease and related dementias (ADRD) and their caregivers experience
loneliness and isolation at greater rates and solutions to increase social connectivity in these populations are
needed. However, existing interventions are often limited in reach, fail to overcome significant barriers to
scalability, and are not specifically tailored towards the effective engagement of individuals with ADRD and their
caregivers. Determined Health created the Connect CallHub (CCH) to provide an end-to-end solution for
organizations seeking to combat social isolation and improve health and well-being, with particular
emphasis in meeting the needs of individuals living with ADRD and informal caregivers of people with
ADRD. Facilitating safe, secure, meaningful, and effective engagement, the platform addresses isolation while
establishing an infrastructure to target a full range of social determinants of health (SDoH) – the factors related
to where/how people live, learn, work, and play that profoundly impact health and well-being. Driving digital
transformation across these efforts will enable effective collaboration between disparate stakeholders invested
in improving the health and well-being of vulnerable seniors while reducing healthcare costs. The overall
objectives of this Phase I SBIR project are to deploy key features that will improve the CCH platform and to
ensure the feasibility of using this updated platform with individuals with ADRD and their caregivers. Aim 1:
Feature Development: Using insights from initial beta-testing, further develop the software to increase
capabilities and features. Milestones include deploying new features such as SMS, email, and voice
communications to all users or select user groups; voice automated surveys for measurement and screening to
facilitate data collection for process improvement and clinical validation studies; and refinement of reporting and
user dashboards to track key call metrics. Aim 2: Feasibility (usability/acceptability): Conduct a pilot
assessment of the updated platform and its acceptability across the ecosystem of stakeholders and end-users.
Milestones include 1) qualitative and quantitative data collection and synthesis and 2) collaboration across the
ecosystem for an assessment of the feasibility of using the platform for reaching a population of patients with
ADRD and caregivers of people with ADRD, validating new features for broader distribution so that efficacy
studies can be performed. This will lay the groundwork for a Phase II SBIR application to scale deployment and
evaluate whether CCH is effective among these populations in reducing social isolation, anxiety, depression,
and overall healthcare costs and whether data collected over the platform can be leveraged to improve detection
of unmet SDoH needs, detect changes in cognition, and assist efforts to support aging in place.

Public health relevance
Social isolation and loneliness accelerate cognitive and functional decline, increase premature mortality, significantly reduce quality of life, and are associated with inefficient, ineffective, and costly care in older Americans. There is a significant unmet need to adequately address isolation among the millions of Americans living with Alzheimer’s disease and related dementias and those who care for them – both groups that experience loneliness and social isolation at increased rates. Through this Phase I SBIR project, Determined Health will further develop its Connect CallHub platform as a tool to increase social connectivity and address related social determinants of health among persons with ADRD and their caregivers, improving their health and well-being.